R01 Renewal: Collaboration of chromatin remodeling and signaling pathways in pluripotency

ABSTRACT
Functional specialization in a multicellular organism arises when cell fate is established by a specific gene
expression pattern. During development from a totipotent cell this is accomplished by the synthesis of spatial
and signaling cues that result in epigenetic modifications to elicit unipotent gene expression. Once established,
such gene expression patterns are stable unless disrupted by disease or injury. Remarkably the over
expression of a few proteins can result in reprogramming of an established cell fate to generate induced
pluripotent stem cells (iPSCs) that have the potential to develop into any of the cells of an embryo just like
embryonic stem cells (ESCs). iPSCs are the ideal starting point for regenerative therapy since they overcome
the ethical and practical concerns of using ESCs. Thus reprogramming provides an ideal model system to
mechanistically define cell identity safeguards. However a critical barrier to studying reprogramming is the low
efficiency (~3%) and differential kinetics (2-3 weeks) of obtaining iPSCs, so that heterogeneous transcriptional
changes are masked in population based studies. We have generated a high efficiency system that combines
epigenetic and signaling regulators. Using this system, in this proposal we will determine the most
parsimonious route of reprogramming to iPSCs and elucidate the chromatin transitions in cells that become
reprogrammed.

Public health relevance
PROJECT NARRATIVE The creation of induced pluripotent stem cells (iPSCs) by the process of reprogramming of somatic cells to an embryonic stem cell (ESC)-like state represents a remarkable cell fate change. iPSCs are functionally equivalent to ESCs in the potential to form many other cell types in response to differentiation stimuli, overcome both the practical and ethical limitations of ESCs and have the additional attractive property in that they can be tailor-made for each patient or at least for each HLA-type in a population thus minimizing chances of immune rejection of replacement tissue. In this proposal we will gain a significant understanding of the mechanism of reprogramming which will be highly impactful in translating the use of iPSCs for therapeutic purposes.